DNA Damage & DNA Replication: a Complex Relationship

PROJECT SUMMARY/ABSTRACT
Our overarching goals are: i. to define the mechanism(s) of ATM activation by the Mre11 complex; ii. to
define the role(s) of the Mre11 complex in DNA replication; iii. To define the role(s) of the Mre11 complex in
response to DNA replication stress. As part of the emphasis of DNA replication stress, our focus includes
RTEL1 which acts to mitigate replication stress at the telomere. A combination of yeast and mouse genetics,
biochemistry, and structural biology are employed to address these issues. Our previous work on these topics
led to substantial scientific progress and insight regarding processes relevant to human health. Specific areas
of inquiry are:
• Genetic screens in yeast and mining of cancer genomic data revealed separation of function Rad50
mutations that affect ATM dependent DNA damage signaling without affecting the DNA repair functions
of the Mre11 complex. These mutations constitute a resource for deciphering the mechanism by which
the Mre11 complex activates the ATM kinase to initiate DNA damage signaling.
• We have modeled three recurrent tumor borne mutations in mice that were confirmed to be
hypomorphic for ATM activation but proficient in DNA repair. These animal models offer a unique
opportunity to delineate Mre11 complex-dependent ATM functions.
• We have identified factors that function at the DNA replication fork in a manner that depends on the
Mre11 complex. An important focus of our laboratory is to understand the functional role(s) of those
factors. Defects in factors that promote accurate DNA replication are highly correlated with human
disease, and so understanding this fundamental process is an important priority in our work.
• Whereas the Mre11 complex functions at the replication fork, RTEL1 is a helicase that promotes
accurate replication of telomeric DNA. We have discovered that RTEL1 influences the abundance and
disposition of a long non coding RNA, called TERRA, that is transcribed from the subtelomeric regions
of all eukaryotes. Our goal in this aspect of our work is two fold. First, to understand the role of RTEL1
in maintaining telomere stability. Second, to use that information to shed light on the function of
TERRA, which is a long standing question.

Public health relevance
PROJECT NARRATIVE Genome instability is a hallmark of cancer, and defects in the DNA damage response, which is required for the maintenance of genome stability are associated with cancer as well as human syndromes associated with reproductive, developmental and neurological defects. We address the functions of the Mre11 complex and RTEL1, both of which have been implicated in human chromosome instability syndromes associated with increased risk of malignancy, bone marrow failure, developmental abnormalities. The experiments described examine the roles of these proteins in the DNA damage response, and have the potential to provide insights regarding the mechanisms underlying human disease including cancer and immune deficiency.